Clinical Protocol and Data Management

Abstract: Clinical Protocol and Data Management (CPDM)
Clinical Protocol and Data Management (CPDM) at the UPMC Hillman Cancer Center (HCC) is supported by
the Department of Clinical Research Services (CRS). CRS facilitates the development, implementation,
coordination, internal data monitoring, and completion of both pediatric and adult oncology-focused trials. CRS
supports national, external peer-reviewed, institutional, and industry trials at all phases, involving all treatment
modalities, with 413 active trials in 2018, including 266 early phase (Pilot, Phase 1/2), 72 Investigator-Initiated
Trials (IITs) of which 43 are developed by HCC investigators, and 96 national trials (DT4). HCC accrued 1,843
patients on interventional trials of whom 745 were on therapeutic trials in CY 2018, and 12,752 Interventional
accruals of which 4,197 are therapeutic during the current reporting period. CPDM/CRS supports HCC
institutional (i.e., investigator-initiated), multi-center cooperative group/National Clinical Trial Network (NCTN),
consortium, and industry-sponsored trials. CPDM leadership was modified in 2018 with the appointment of
Antoinette Wozniak, MD, an experienced clinical investigator, as the Associate Director (AD) for Clinical
Research to oversee the development of the scientific strategy for HCC and the promotion of investigator-
initiated clinical research to take advantage of the strong basic and translational scientific programs at HCC.
Also new in 2018, Bhanu Pappu, PhD, MHA, joined as the AD for Clinical Research Operations and provides
day-to-day administrative oversight of CRS and executes the strategic plan. Since their arrival in 2018, they
have streamlined several processes, started new initiatives to decrease clinical trial activation times, increased
staff retention, allocated CPDM staff based on trial complexity, strengthened internal audit processes, and
enhanced collaborations with the expansive UPMC community oncology practices. Early trends indicate that
clinical trial activation times have decreased significantly and patient enrollment on therapeutic clinical trials
has increased by 30% in 2019 compared to 2018. Data and Safety Monitoring is an integral part of the CPDM
which is overseen by the Data and Safety Monitoring Committee (DSMC) and supported by the internal audit
team as well as the Education and Compliance Office of the University of Pittsburgh. An independent safety
team ensures that all disease or modality centers (DMC) across HCC follow the same SOPs for patient safety
reporting and submits its reports to the DSMC Chair. Participation of women continues to be high (67%
accruals in 2018 are women). Minority participation is stable (5.4%) and closer to the percentage of minority
patients seen at HCC, but HCC leadership recognized the need and opportunity to increase minority
enrollment, hence various strategies to enhance minority trial participation are outlined in Part III of CPDM. The
Pediatric Oncology Program at Children’s Hospital of Pittsburgh is integrated with HCC and recruited 60
patients on clinical trials out of 164 analytical cases in 2018 (37%).